Molecular Functions of BRCA2 and RAD51 Paralogs in Homologous Recombination and Chromosome Maintenance

Project Summary/Abstract
The broad objective of this proposal is to understand the molecular mechanism of homologous
recombination (HR) in humans, and to understand how the consequences of defects in recombinational DNA
repair result in chromosomal instability that underlie the predisposition to cancers. The proteins involved in a
central step of HR, DNA pairing, include RAD51, BRCA2, and the RAD51 paralogs, RAD51B, RAD51C,
RAD51D, XRCC2, and XRCC3. Mutations in these proteins are known to predispose individuals to cancer. The
objective is to understand the functions of these proteins in genome maintenance via recombinational DNA
repair, and how these proteins mediate and potentiate homologous DNA pairing by RAD51. We propose to
understand their mechanisms of action through biochemical analyses of reconstituted reactions using purified
proteins; characterization of defective mutant proteins identified in the patient population, and by visualizing the
individual behavior of these proteins acting on single molecules of DNA. The Specific Aims are to understand
the molecular functions of BRCA2 protein and to determine the functions of the RAD51 paralogs in RAD51
filament formation and RAD51-dependent DNA pairing.

Public health relevance
Project Narrative DNA repair by homologous recombination (HR) is a fundamental biological process necessary for the maintenance of chromosomal integrity. The failure to maintain genomic integrity is a major source of predisposition to cancer. The research in this proposal will focus on molecular events essential for chromosomal maintenance by homologous recombination which, when defective, is known to result in predisposition to cancers, and also to hematological malignancies, bone marrow failure, and developmental abnormalities in Fanconi’s anemia.